Noradrenergic Regulation in the BNST

Abstract/Summary:
Relapse is a barrier in addiction treatment, and stress is a precipitating stimulus. α2-adrenergic receptor (AR)
agonists can block stress-induced reinstatement of drug-seeking in animal models, particularly through their
actions in a region of the brain known as the bed nucleus of the stria terminalis (BNST). However, in the
previous funding period we found unexpected pro-reinstatement actions of these receptors which may limit the
clinical effectiveness of α2-AR agonists. Moreover, the finding that pro-reinstatement α2a-ARs exist provides a
potential way to determine neuronal circuits controlling reinstatement. We also found that α2a-ARs in the BNST
induce an unexpected form of neuronal excitation despite coupling to “inhibitory” Gi heterotrimeric G-proteins,
and that this excitation may participate in inducing reinstatement of drug-associated behaviors. Thus, we
hypothesize that a BNST neuronal ensemble is excited by the α2-AR agonist guanfacine to drive reinstatement
of drug-associated behavior. We propose experiments in this application to 1) determine the functional circuitry
of BNST cells activated through this process, 2) test the hypothesis that this excitation occurs by decreased
cyclic AMP signaling to alter the function of hyperpolarization-activated cyclic nucleotide gated channels in
these cells, and 3) directly test the hypothesis that these cells drive reinstatement of drug-associated
behaviors. The successful completion of these studies will facilitate rational choices regarding therapeutics
likely to reduce stress-induced drug seeking behavior.

Public health relevance
Narrative: Addiction poses an enormous health and financial burden on our society. Currently, our understanding of the brain circuitries involved in addiction is far from complete. The successful completion of these proposed studies would result in important new information about neurons that may be involved in addiction, potentially creating new targets for therapeutic development.